Mechanisms of gene regulation in cancer

ABSTRACT
This proposal provides salary support for a highly productive Research Specialist, Dr. Charly Good, working in
the lab of a well-established Unit Director, Dr. Shelley Berger. This proposed work is an integral part of Dr.
Berger's NCI funded cancer research program, which focuses on understanding how wildtype (WT) and gainof-
function (GOF) mutant p53 sculpt the genome for gene regulation. p53 is a transcriptional activator that
directly binds DNA to induce tumor suppressor gene expression. Dr. Berger's group has made seminal
discoveries in how p53 functions in cancer, including the groundbreaking discovery that select hotspot
mutations in p53 (GOF p53) confers oncogenic abilities through activation of key epigenetic pathways.
Understanding how GOF p53 regulates its target genes is a major question that, after exhaustive study, still
remains unanswered. Enhancer clusters (ECs) are groups of enhancers that cluster together in 3D space to
drive high levels of gene expression. Dr. Good is currently addressing the following questions. 1) what proteins
interact with GOF p53 to drive cancer growth? 2) does GOF p53 reorganize ECs to drive high levels of gene
expression? 3) what transcription factor(s) does GOF p53 collaborate with to rewire ECs? 4) what target genes
does GOF p53 regulate via rewiring of ECs? P53 also regulates genes by bringing them close to nuclear
speckles (NS) to boost expression. Dr. Good is mentoring trainees in the lab to 5) identify which GOF p53
target genes associate with NS and test the function of this regulation and 6) identify how p53 associates with
NS by identifying the proteins that interact with the praline rich domain of p53. Dr. Good will be responsible for:
(1) generating the high-throughput HiChlP, RNA-seq, and Poree datasets in cancer cells with WT and GOF
p53 mutations; (2) analyzing the sequencing data to identify how normal WT p53 functions at ECs and
importantly, how GOF p53 rewires ECs to promote cancer growth; (3) performing molecular biology
experiments and cancer assays to test the functional consequences of disrupting critical ECs and nuclear
speckle association using CRISPR gene editing approaches. This work will be viewed with a translational lens,
whereby all genomics data will be analyzed in a way that offers clinically relevant insights to improve upon
patient therapy. Dr. Good is also involved in the ongoing T cell work in the Unit Director's lab, publishing
several first-author papers on T cell exhaustion in cancer and mentoring trainees in this area. Dr. Good has
worked with Dr. Berger since 2017. Together, they have published numerous high-quality manuscripts and
have advanced our understanding of cancer biology. Dr. Good is a key resource in Dr. Berger's laboratory,
where she directly mentors graduate students and postdocs and teaches both wet and dry lab techniques to
trainees. The Research Specialist award would be a tremendous opportunity for Dr. Good and would support
her career development as a staff scientist. She will be instrumental in advancing the robust cancer research
program in Dr. Berger's laboratory and will help to train the next generation of scientists.

Public health relevance
PROJECT NARRATIVE p53 is the most frequenUy mutated gene in human cancer and we show that select mutations in p53 drive cancer growth. Our work will illuminate new ways that mutant p53 regulates gene expression to drive cancer growth. We hope that these studies will lead to new therapeutic approaches for patients with p53 mutations.